OHSU Women's Reproductive Health Research K12 Program

SUMMARY
The Oregon Health & Science University (OHSU) Women's Reproductive Health Research (WRHR) K12
Program seeks continued support to recruit, train, mentor and launch the next generation of OB/GYN physicians
to transition into independent physician-scientists and academic leaders in women's reproductive health. The
OHSU WRHR K12 program leverages the multidisciplinary basic, translational, and clinical research
opportunities, research facilities, faculty and infrastructure, and educational programs for the development of
early-career OB/GYN physician investigators at OHSU. It also builds upon long-standing collaborations between
the OB/GYN Department and prominent OHSU Centers, Institutes, and Departments, including the Oregon
National Primate Research Center, and the Knight Cardiovascular and Cancer Research Institutes to provide
guidance and support to WRHR K12 Scholars. OHSU's WRHR K12 program has a tradition of multi-faceted
research and training in reproductive biology and women's health and wellbeing utilizing a life course approach;
of the 14 Scholars enrolled in the program, 2 are currently active, 1 transitioned to a different K12 Program
(RSDP), and 11 have completed the program and achieved research independence demonstrating exemplary
track records of scholarship, funding, and research productivity. Over the next 5 years, we propose to continue
support of our 2 current Scholars who are exceeding expected milestones and making excellent progress
towards their specific aims and will appoint at least two additional Scholars. In addition, we will build upon the
growing diversity of the WRHR applicant pool and focus efforts on recruiting Scholars from groups
underrepresented in medicine. We will also continue to expand the research and career opportunities of Scholars
to include emerging, cutting-edge scientific fields. The primary objective of the OHSU WRHR K12 program is
to transition highly-qualified OB/GYN physicians to become reproductive scientists and national leaders in
women's health. Specific areas of emphasis are: (1) contraceptive development, effectiveness, and impact; (2)
developmental origins of health and disease (DOHaD); (3) reproductive biology including ovarian and uterine
function and dysfunction, the developing embryo and fetus; (4) maternal physiology, pathophysiology, pregnancy
care and complications, and the outcomes of women and their offspring; and (5) female-specific and gynecologic
conditions in women. Upon successful completion of the WRHR Program, Scholars will have expertise in
research investigation and the skills required to become independently funded physician-scientists in
reproductive health and academic leaders that advance women's health and wellness.

Public health relevance
PROJECT NARATIVE The Oregon Health & Science University (OHSU) Women's Reproductive Health Research (WRHR) K12 Program seeks continued support to recruit, train, mentor and launch the next generation of OB/GYN physicians to transition into independent physician-scientists and academic leaders in women's reproductive health. The primary objective of the OHSU WRHR K12 program is to train highly-qualified OB/GYN physicians to become reproductive scientists and national leaders in women's health with the following specific areas of emphasis: (1) contraceptive development, effectiveness, and impact; (2) developmental origins of health and disease (DOHaD); (3) reproductive biology including ovarian and uterine function and dysfunction, the developing embryo and fetus; (4) maternal physiology, pathophysiology, pregnancy care and complications, and the outcomes of women and their offspring; and (5) female-specific and gynecologic conditions in women. Upon successful completion of the WRHR Program, Scholars will have expertise in research investigation and the skills required to become independently funded physician-scientists in reproductive health and academic leaders that advance women's health and wellness.